Targeting LIGHT for treatment of glomerulonephritis

Project Summary
Crescentic glomerulonephritis (CGN) is a severe immune-mediated condition that causes a rapid deterioration
in renal function, but the mechanisms that regulate this pathogenic immune response are poorly understood.
This gap in knowledge has led to an absence of targeted treatments for this condition, as the current standard
immunosuppressive agents (ISAs) are plagued by poor efficacy and off-target toxicity. In this project, we seek to
solve this dilemma through the development of a first-in-class, kidney-draining lymph node (KLN)-targeted
nanotherapeutic. Previous studies examining the pathogenesis of CGN have focused on identifying potential
therapeutic targets in the kidney, but our group has demonstrated that the KLN is the major site for regulation of
the adaptive immune response during CGN. Here, we have focused our studies on fibroblastic reticular cells
(FRCs), the chief cells that create and maintain the stromal compartment of lymph nodes (LNs). FRCs form the
microarchitecture of the LN, supporting specialized blood vessels called high endothelial venules (HEVs) that
mediate the entrance of naïve T cells into the LN, and they produce extracellular matrix (ECM) fibers and conduits
upon which these T cells interact with dendritic cells inside the LN. We found previously that FRCs are integral
to renal damage, as their selective ablation ameliorated kidney injury during the acute phase of CGN. However,
the specific signaling pathways that confer pro-inflammatory properties to FRCs are unknown. Our preliminary
data shows that the cytokine TNFSF14 (LIGHT) induces a pro-inflammatory phenotype in FRCs, and that LIGHT
is also expressed by kidney proximal tubular epithelial cells (PTECs) during CGN. Furthermore, we found that
LIGHT produced by both CD4+ T cells and proximal tubular epithelial cells (PTECs) is integral to kidney injury
during CGN, using cell-specific conditional LIGHT knockout mice. Meanwhile, we have created first-in-class
antibody-coated nanoparticles (NPs) that traffic selectively to LNs through binding to a specific family of
glycoproteins on HEVs known as peripheral node addressin (PNAd). Importantly, these NPs could satisfy the
critical unmet need for targeted therapeutic development for CGN. In this proposal, we will test the hypothesis
that LIGHT activity in both the KLN and kidney contributes to the pathogenesis of CGN, and the use of a KLN-
targeted anti-LIGHT nanotherapeutic will ameliorate CGN. We will interrogate this hypothesis by pursuing three
complementary specific aims. In Specific Aim 1, we will define the mechanism by which CD4+ T cell-produced
LIGHT promotes a pro-inflammatory milieu in the KLN to exacerbate CGN. In Specific Aim 2, we will define the
mechanism by which PTEC-produced LIGHT contributes to kidney injury during CGN. In Specific Aim 3, we will
build a first-in-class, KLN-targeted nanodelivery platform for anti-LIGHT to treat CGN. These experiments will (1)
illuminate the understudied contribution of KLN FRCs to the pathogenesis of CGN, (2) highlight PTECs as active
initiators of the immune response via expression of LIGHT in the kidney, and (3) introduce LIGHT as a potential
therapeutic target in CGN through the development of first-in-class, KLN-selective anti-LIGHT nanovehicles.

Public health relevance
Project Narrative Crescentic glomerulonephritis (CGN) is a severe condition that can cause kidney failure within days, but it lacks an effective targeted treatment. In this project, we will seek to understand how the inflammatory protein LIGHT impacts this condition both in the kidney and the kidney-draining lymph node. Then, we will construct a first-in- class drug carrier that will deliver a medication to the kidney-draining lymph node that inhibits LIGHT activity, providing a potential solution for the current absence of precision medicine for CGN.